Administrative Core

The Administrative Core (ADMIN) for the Center for Social Capital (SoCa) will be essential for meeting the Center’s mission to reduce disparate cancer risks and outcomes in persistent poverty areas (PPAs) in the New York City (NYC) Region. The ADMIN will fully leverage the research and training resources and infrastructure of Cornell University (CU), Columbia University Irving Medical Center (CUIMC), and Downstate Health Sciences University (Downstate), and the regional healthcare systems and networks of New York-Presbyterian (NYP) Hospital System, NYP Dalio Center for Health Justice, and New York City Departments of Health and Education, to conduct cancer risk reducing interventions to alleviate disparate cancer risks and outcomes in persistent poverty areas. In order to build capacity and cultivate the next generation of investigators equipped to reduce disparate cancer risks in PPAs, the SoCa Center has four Cores to support its’ mission: ADMIN, Career Enhancement Core (CEC), Developmental Core (DC), and Research and Methods Core (RMC).
The central theme of the SoCa Center revolves around building social capital as a means to alleviate the impact of disparate cancer risks and outcomes in persistent poverty areas. We have designed two complementary projects that focus on novel interventions aimed at two structural determinants of health—education and health care services. The ADMIN will oversee, manage, and coordinate the range of activities for the entire SoCa Center. Within the ADMIN, we will also facilitate the interactions between the investigators involved in all Center Projects, including the DC pilots, and those led by SoCa Health Scholars, community organizations, and mentors. The ADMIN will use a coalition approach to support our mission of promoting multigenerational health and reduce disparate cancer risks and outcomes in PPAs. The ADMIN will: (1) centrally manage and coordinate all Center research and activities to promote synergy and facilitate connections across the Center and will provide administrative, financial, and scientific support to collaborative research teams across the Center (Aim 1); monitor research progress and milestones for all Center activities, including all Cores and Projects, and ensure implementation of the Center Plans through formal feedback and ongoing evaluations (Aim 2); and promote a community-engaged research agenda, engage early stage investigators in cancer control research, and disseminate research approaches, methods, findings and opportunities across our NYC Region and through the larger NCI Persistent Poverty Initiative Network (Aim 3).
The SoCa Center’s ultimate impact in eliminating health disparities in cancer control in persistent poverty areas in the NYC Region will come from our collective efforts in developing, and building capacity in training and research opportunities focused on strategies aimed at multilevel interventions that look beyond those focused on the individual. The ADMIN will support this mission.